Impaired B Cell and Vaccine Responses with Advance Renal Disease

Bacterial infections are the second leading cause of death in ESRD. The incidence of pneumonia amongst
dialysis patients is increasing and leads to a mortality rate that is 14-16-fold greater than pneumonia in the
general population. Little is known regarding the immune response to pneumococcal vaccination in patients with
CKD and ESRD. Preliminary data suggests that antibody production and duration in response to pneumococcal
vaccines is reduced in CKD and ESRD. The cause of decreased antibody production and duration in response
to pneumococcal vaccines is unknown.
CKD and ESRD may impair B cells directly and reduce the ability of T follicular helper (TFH) cells to
support effective B cell selection and differentiation. Production of antibodies of high specificity, affinity, and,
thus, function is derived from the frequency and pattern of mutation in immunoglobulin genes that encode the
antibody’s antigen-binding variable region (VH) in response to infection or vaccine. Development of effective
antibodies requires serial mutations in VH genes by somatic hypermutation (SHM) and changes in the effector
constant region from IgM to IgG or IgA by class switch recombination. Both processes require the DNA editing
enzyme AID (activation-induced cytidine deaminase) in B cells in lymphoid germinal centers (GC). The effect
of CKD on B cell maturation, SHM, class switch recombination and AID is unknown.
We will characterize mucosal (nasopharyngeal) and systemic B cell and antibody responses to PCV-13 among
adults with CKD and determine:
a) Whether CKD impairs levels of PPS-specific IgA and IgG in nasal mucosa and in blood with PCV-13, and
differential expression of specific IgG1/2 and IgA1/2;
b) Whether the quality (avidity) and function (opsonophagocytosis) of PPS-specific mucosal (nasopharyngeal)
and systemic IgA and IgG are compromised by CKD.
c) If PPS-specific IgG1/2 (and IgA1/2) show differential i) production with PCV-13 with CKD in blood and
nasopharyngeal mucosa. ii) killing of S. pneumoniae.
We will determine whether CKD impacts the mutation frequency of VH genes in PPS-specific B cells in
association with impaired TFH and AID responses after PCV-13 vaccination.
a) Characterize the frequency, diversity, clustering and VH gene mutation frequency in pneumococcal capsule-
specific IgG antibody-secreting cells in each group on day 7 after PCV-13;
b) Determine TFH cell recruitment and activity, expression of AID in B cell subsets pre- and post-stimulation by i)
mRNA for AID and ii) intracellular AID protein expression.
c) Determine the contribution of chronic inflammation (eg., IL-6, TNF-α) in CKD on TFH and AID responses and
capsule-specific antibody levels, avidity, function after PCV-13.

Public health relevance
Chronic kidney disease (CKD) and End-Stage Renal Disease (ESRD) affect over 37 million Americans, or approximately 15% of the population. Bacterial infections are the second leading cause of death in ESRD and are an important cause of hospitalization. B cells are important components of the immune response to infections. CKD and ESRD affect the ability of B cells to make antibodies that fight bacteria and respond to vaccines, thus leaving Veterans vulnerable to infection. Therefore, understanding how CKD and ESRD reduce the ability of B cells to make antibodies would represent a key therapeutic advance that would improve Veteran care. We propose novel experiments to understand B cell impairment in Veterans with CKD and ESRD that we expect to lead to new therapies.